BIOENGINEERING OF 3D TISSUES AND MICROPHYSIOLOGICAL SYSTEMS TOWARDS LONGEVITY EXTENSION FOR MODELING OF ACUTE AND CHRONIC EXPOSURES TO STRESSORS

NASA, NIH, BARDA and FDA are partners in a collaborative solicitation that will include research that will extend the tissue viability and physiological function to a minimum of 6 months of tissue chips or microphysiological systems, as well as incorporate automated engineering capabilities for real-time online readouts in these complex human in vitro model systems. These advances in tissue chip capabilities will allow all partners to employ these platforms for scientific understanding of the influence of multiple types of long-lasting or chronic stressors on tissue or organ systems and facilitate the translation of results to humans.